University of Washington Developmental AIDS Research Center for Mental Health (UW ARCH)

PROJECT SUMMARY/ABSTRACT
People with HIV who are releasing from prison are at elevated risk of dropping out of HIV care,
transmission of HIV to others, and mortality, specifically mortality due to drug overdose. Opioid use disorder
(OUD) is a preventable risk factor for poor linkage to community-based HIV care, nonadherence to
antiretrovirals, HIV transmission, and overdose after release from prison. Medication for OUD (MOUD)
decreases HIV risk behaviors, opioid use, and overdose and is now available in many prisons, including
Washington state prisons. Determining whether people have OUD is necessary to ensure that the appropriate
patients initiate MOUD and link to addiction services upon release. Identification of people with OUD, however,
is complex in the prison setting. Few OUD assessment tools are validated in justice-involved populations, and
those that exist are not necessarily widely implemented. HIV transmission risk assessment could be integrated
into OUD assessment, providing a comprehensive picture of risk and ensuring status-appropriate referrals to
HIV care or prevention services upon release. We are aware of no HIV risk assessment tools that are widely
used in prisons, though community-based instruments are available. Prisons are complex implementation
environments, due to stigma of OUD and HIV, understaffing, and a primary focus on public safety not public
health; this necessitates an implementation-focused approach to integration of OUD and HIV risk assessment.
The goals of this supplement application are to 1) understand the perspectives of key stakeholders on
identification of OUD and HIV risk among people in prison and 2) work with Washington prison stakeholders to
select appropriate tools for OUD and HIV risk assessment and select and adapt implementation strategies to
integrate these tools into routine practice. We will first conduct a total of 45 interviews with three groups of
stakeholders: 1) Washington prison staff, 2) incarcerated people, and 3) recently released people with HIV or
HIV risk. We will then observe existing prison health assessment practices to identify barriers and facilitators to
identifying OUD and HIV risk. Finally, we will convene a focus group (n=12) that will meet four times to select
tools for OUD and HIV risk assessment and adapt implementation strategies. This work will be guided by the
Exploration, Preparation, Implementation and Sustainment (EPIS) framework, and the focus groups will build
on principles of Human Centered Design. Our experienced interdisciplinary team, led by Dr. Jack (physician-
scientist practicing primary care in Washington prisons) and Dr. Hamilton (addiction health researcher with
focus in criminal legal populations) will conduct this multi-staged formative study with support from an HIV
expert (Dr. Graham), implementation science expert (Dr. Glass) and behavioral health assessment expert (Dr.
Bradley) along with feedback from community partners. This formative work will inform a follow-up study to
pilot the implementation strategies and validate an OUD assessment tool in prisons.

Public health relevance
PROJECT NARRATIVE Release from prison is a high-risk time for dropout of HIV care, lack of viral suppression, HIV transmission, and mortality. Identifying opioid use disorder and HIV risk while people are incarcerated is essential for initiating evidence-based opioid use disorder treatment and improving care in transition to the community. We propose to conduct formative work, including interviews, routine practice observation, and focus groups, to identify practical assessment tools for OUD and HIV risk and adapt implementation strategies for integration of OUD and HIV risk assessment into routine practice in a state prison system.